Resolving epigenetic instability during pluripotent state transitions: a roadmap for exploiting the biomedical potential of dynamic human stem cell states

ABSTRACT A major goal of stem cell research is to derive high-quality human pluripotent stem cells (hPSCs) that possess the unique transcriptional, epigenetic and functional properties of developmentally unrestricted “naïve” pluripotent cells found in the pre-implantation blastocyst in vivo. In contrast, hPSCs derived under traditional conditions represent a more advanced or “primed” developmental state that corresponds to the late post-implantation epiblast. My work and that of others has shown that primed hPSCs can be repro- grammed into a naïve state marked by expression of early embryonic transcription factors, globally re- duced DNA methylation levels and X chromosome reactivation in female cells. However, the widespread utilization of naïve hPSCs in biomedical research is currently impaired by epigenetic instability during es- tablishment and maintenance of the naïve state. In particular, naïve hPSCs generated with currently avail- able methods display irreversible erasure of parent-specific imprinting and retain an epigenetic memory of the inactive X chromosome in female cells. Based on recent studies in mouse, and my preliminary data in human cells, I hypothesize that aberrant epigenetic reprogramming during induction of na- ïve pluripotency is a consequence of inappropriate signal perturbation. I will employ reporter-based combinatorial chemical screening to capture naïve hPSCs that faithfully recapitulate the epigenome of human pluripotent cells in vivo, and apply these insights to establish novel stem cell models of human disease. My specific goals are to preserve parent-specific imprinting during induction of naïve pluripotency, enable random XCI upon differentiation in female cells, and assess the competence of epigenetically stable naïve hPSCs for unbiased differentiation into all three germ layers. In addition, I propose to exploit the unique properties of naïve hPSCs to investigate disease mechanisms that cannot be adequately modeled in conventional hPSCs, such as the epigenetic basis of early pregnancy loss and X-linked disorders. The overall aim of this project is to exploit the presently untapped biomedical potential of naïve hPSCs and generate a robust cellular platform for disease modeling and regenerative medicine.

Public health relevance
Project narrative Recent years have seen significant interest in the isolation of “naïve” human pluripotent stem cells that closely resemble pluripotent cells found in the human blastocyst in vivo. However, current protocols for capturing naïve human pluripotency in vitro cause irreversible loss of parental imprinting and do not support random X chromo- some inactivation upon differentiation. I propose to resolve this epigenetic instability by identifying an enhanced signaling environment for inducing and maintaining naïve human pluripotency, and will apply these insights to establish novel stem cell models of reproductive failure and X-linked disorders.